Imaging Core

The Imaging Core will provide the capabilities and services for all imaging needs of the PPG projects. The core will provide technical support and service on image acquisition protocols, image processing and analysis, and will ensure the comparability of results across studies. Specifically, the Imaging Core will provide continued consultation and technical support to investigators, develop imaging protocols and adapt state-of-the-art imaging techniques, provide image data collection and archiving service, provide data analysis services, and offer education about imaging methods and related topics.